Neuro-oncology research

The Neuro-Oncology Branch (NOB) has developed robust scientific programs addressing critical areas of brain and spine cancer research. Our investigators translate laboratory findings into clinical trials that are designed to assess whether a treatment is working and what impact it has on the patient. Each of our research programs has the same goal: to improve brain and spine cancer patient care and outcomes. Our Neuro-Oncology Clinic, located at the National Institutes of Health (NIH) Clinical Center, offers patients expert evaluation, examinations, tests, and imaging; advanced neurosurgery and radiation therapy; and treatments based on the genetic characteristics of a person's specific tumor type. This program encompasses a portfolio of therapeutic clinical trials to treat brain and spine cancer patients, as well as a series of complementary non-therapeutic studies. The NOB's extensive clinical research infrastructure enables our investigators to launch critical studies, including Phase 0 studies using both microdialysis techniques and post-treatment tumor resection to determine tumor drug delivery; Phase I studies with pharmacokinetics and pharmacodynamics; and single arm Phase II studies.